Establishing a Sustainable Master's Degree Program in Research Ethics and Integrity in Morocco

Project Summary/Abstract
Our project aims to significantly enhance Morocco's research ethics capacity and scientific
integrity by developing advanced educational programs and leveraging local expertise. Morocco
faces critical gaps in research ethics, especially highlighted by recent expansions in research
fields with complex ethical considerations, such as oncology, genomics, and international
research. Our goal is to strengthen leadership capacity and expertise in international research
ethics and research methods. The objective is to develop educational programs in Morocco that
encompass critical competencies to provide research ethics education, ethical review leadership,
and expert consultation to researchers, their institutions, governments, and international research
organizations. Another objective is to establish a regional research ethics committee network to
enhance a sustainable and collaborative research ethics community. Our specific aims include:
· Specific Aim #1: In Year 1, we will develop courses for a master’s degree and diploma
programs focused on research ethics and integrity. Concurrently, we will conduct intensive
faculty training to Moroccan Fogarty Scholars to equip them with the necessary skills to
effectively teach the new curriculum and engage in mentoring.
·
Specific Aim #2
: At the onset of Year 2, we will launch the master’s program, utilizing the
newly developed curriculum and fully trained faculty. This aim also includes initiating the
strategically developed diploma programs that serve a diverse range of professionals.
· Specific Aim #3: In Years 2-5, we will conduct a continuous evaluation and enhancement of
the master’s program in research ethics and integrity.
· Specific Aim #4: We aim to establish a research ethics network based in Morocco,
strategically extending across the MENA region to include key partnerships, such as with the
Egyptian Network of Research Ethics Committees (ENREC).
The project will utilize a collaborative approach involving key Moroccan stakeholders and
international experts to develop curriculum and teaching methodologies. The process will be
iterative, with continuous evaluation of program effectiveness and pedagogical outcomes guiding
subsequent program and network development phases. This strategic methodology ensures the
programs address local needs and promote a sustainable culture of research integrity and ethics
in Morocco and beyond.

Public health relevance
Project Narrative Our project focuses on improving how medical research is conducted in Morocco by teaching local professionals research ethics, especially in sensitive fields like cancer studies and genetic research. By training Moroccan academics through new educational programs in research ethics, we aim to ensure that medical research is carried out responsibly and ethically, ultimately protecting patients and the general public.